Rhode Island State Food Testing Laboratories Maintenance and Enhancement of ISO/IEC 17025 -2017 Accreditation

Project Summary / Abstract for State of Rhode Island Maintenance and Enhancement of ISO/IEC 17025 Accreditation and Whole Genome Sequencing for State Food Testing Laboratories Competition A Application Project Summary/Abstract The Rhode Island State Health Laboratories (SHL) is the state food regulatory laboratory accredited to the ISO/IEC 17025:2017 laboratory standards for the FDA Manufactured Food Regulatory Program (MFRPS) provides laboratory support to the state and federal integrated food safety system under the Food Safety Modernization Act. The SHL will continue enhancing its food testing program and while maintaining its accreditation for both of its food microbiology and chemistry laboratories. The SHL seeks to increase the number of samples collected and tested for the MFRPS program by leveraging its longstanding partnership with the state’s food regulatory agency, the RIDOH Center for Food Protection to effectively improve the state’s sampling agreement for MFRPS. The SHL seeks to increase the laboratories’ capacity to provide standardized food testing for the FDA while it maintains conformance with Standard Ten of the MFRPS through training of its scientists and continual systems improvement. SHL will also continue its longstanding partnership with the RIDOH Center for Acute Infectious Disease and Epidemiology to provide laboratory support during foodborne outbreak investigations and emergency response. The SHL will continue to communicate with regulatory laboratories in other states provide insight into how to sustain ISO 17025:2017 accreditation for food testing to achieve their own sustainability. The SHL will continue to implement and meet the electronic formatting requirements as they evolve from FDA for or from eLEXNET. The SHL will continue reporting all food sample test results to the FDA via the eLEXNET database. The SHL will continue its participation as a member of the Food Emergency Response Network (FERN) and a FDA Microbiology Cooperative Agreement Program (MCAP) laboratory.

Public health relevance
Project Narrative for State of Rhode Island Maintenance and Enhancement of ISO/IEC 17025 Accreditation and Whole Genome Sequencing for State Food Testing Laboratories Competition A Application Project Narrative The purpose of this project is to enhance and maintain ISO: IEC 17025:2017 laboratory accreditation of the Rhode Island State Health Laboratories (SHL) serving as the primary food testing laboratory for the FDA Manufactured Food Regulatory Program Standards (MFRPS) program in the state. During the project period SHL will enhance its scope of food microbiology and chemistry laboratories testing under its ISO: IEC 17025-2017 laboratory accreditation. SHL will continue to partner with the RIDOH Center for Food Protection to improve and expand its sampling agreement for the state’s MFRPS program. SHL will continue to build-up the state’s food testing laboratory capability and capacity to provide standardized food testing for the MFRPS surveillance as well as for foodborne outbreak investigations and consumer complaints to assure safety of the public food supply. In addition, under its ISO: IEC 17025-2017 accreditation SHL will continue to provide testing services to existing projects such as the FDA Microbiology Cooperative Agreement Program (MCAP) and as a Food Emergency Response Network (FERN) laboratory. SHL will continue to report all laboratory food testing results to the FDA database Elexnet or to FDA’s next generation database as it develops. SHL is already performing Whole Genome Sequencing and looks forward cooperating with FDA by submitting WGS food testing results to the agency.